Global Network for Women's and Children's Health Research

PROJECT SUMMARY / ABSTRACT
The Eunice Kennedy Shriver National Institute of Child Health and Human Development Global
Network for Women's and Children's Health Research (GN) is a cooperative multicenter network
formed to conduct clinical research in low resource countries with the aim of improving health and
well-being of mothers and children. Indiana University has partnered with Moi University in Kenya to
participate as a Global Network partner since 2008. During these ten years, the lU-Moi University
partnership has established an efficient, productive site in Sub-Saharan Africa. The site consists of 16
clusters located in rural Western Kenya. It has contributed approximately 140,000 (including the
infants) subjects to the Maternal Neonatal Health Registry database (MNH Registry). The consent
rate is greater than 99%. Delivery outcomes are obtained in 96.6% of registered women, and 42-day
follow-up is obtained in 98.2%. The partnership has successfully participated in five completed study
and is currently participating in 2 ongoing GN studies. The principal Investigators of the Kenya site
are Edward A. Liechty, Professor of Pediatrics at Indiana University School of Medicine, and Fabian
Esamai, Professor of Child Health and Principal of the College of Health Sciences, Moi University,
Eldoret, Kenya. Dr Sherri Bucher will join this cycle as Co-PI. Dr Liechty and Professor Esamai have
established a productive scientific endeavor based on a long-term relationship of mutual respect and
cooperation. Their collaboration began in 2003, when Dr Liechty was a Fulbright Research Scholar at
Moi University. At the time. Professor Esamai was head of the Department of Child Health and
Pediatrics. Since then Professor Esamai has been Dean of the School of Medicine (2006-2009) and
most recently appointed the inaugural Principal (i.e. Vice Chancellor) of the newly established Moi
University College of Health Sciences. In addition to this position within Moi University, Professor
Esamai also is a frequent consultant to the Kenya Ministry of Health and the World Health
Organization. Moi University has an excellent existing research infrastructure, including a duly
constituted IRB and a fully functional grants financial management office. The site is a strong partner
in the Global Network

Public health relevance
PROJECT NARRATIVE The Indiana University-Moi University partnership will continue to serve as a site for multicenter international clinical research in Women's and Children's health. Particular focus will be on culturally appropriate public health interventions to improve the outcome of pregnancy for women in low resource countries.